FDA LFFM: Discipline- Special Projects - Analytical Track-NFSDX Integration or ORAPP Adoption at CT AES

PROJECT SUMMARY- NSFDX AND ORAPP INTEGRATION PROJECT FDA LFFM: Discipline-Special Projects; NFSDX and ORAPP Integration at CT AES Project Summary- This proposal is being submitted in response to RFA-PAR-20-105 Laboratory Flexible Funding Model (LFFM)(U19). The Connecticut Agricultural Experiment Station (CT AES) has a 145-year history of food safety research, including 15 years as a member of the FDA Food Emergency Response Network (FERN) Chemistry Cooperative Agreement Program (cCAP), and 8 years of funding under 4 different FDA ISO food/feed safety CAPs. Under this project, we will work with FDA to enhance our current data systems to facilitate electronic submission of sample analysis data to FDA. We note that we have been submitting data electronically through eLEXNET since 2012 and have begun working with FDA on transitioning to NSFDX. As such, we will complete this project in year one of the cooperative agreement. The Research Strategy describes our plan to meet the Track-Specific Aims described in the RFA, including assessing, enhancing, and integrating current IT systems, participating in onboarding and collaboration meetings and entering a Memorandum of Understanding (MOU) and Interconnection Security with FDA. The CT AES has demonstrated the expertise, capability, and adaptability to fully meet the objectives of this RFA through our successful participation in a number of FDA CAPs. Receipt of this new award from FDA will significantly enhance the ability of the CT AES specifically, and CT in general, to meet the program goals laid out in the RFA, and as described by the President’s Food Safety Working Group, the Partnership for Food Protection and the Food Safety Modernization Act. 1

Public health relevance
The Connecticut Agricultural Experiment Station 123 HUNTINGTON STREET, P.O. BOX 1106, NEW HAVEN, CONNECTICUT 06504 Putting Science to Work for Society Protecting Agriculture, Public Health, and the Environment Founded 1875 RFA-PAR-20-105 Laboratory Flexible Funding Model (LFFM)(U19) Project Narrative: The Connecticut Agricultural Experiment Station (CT AES) has a 145-year history of food safety research, including 15 years as a member of the FDA Food Emergency Response Network (FERN) Chemistry Cooperative Agreement Program (cCAP), and 8 years of funding under 4 different FDA ISO food safety CAPs. CT AES participates in a number of surveillance and monitoring programs to ensure the safety of food and feed in the state, with both the FDA and other state agencies. This work also occurs as part of our current activity with FDA FERN cCAP, as well as our MFRPS (human food) and AFRPS (animal food) work for FDA and CT. CT AES has been submitting sample data to eLEXNET through an automatic data exchange since 2012 and has begun to work with FDA on a transition to NSFDX. The primary goal of the proposed Discipline D: Special Project is to enhance our current data systems so as to enable seamless electronic submission of sample analysis data to FDA. We will accomplish the Project in year one of the grant. Phone: (203) 974-8500 Fax: (203) 974-8502 Toll Free: 1-(877) 855-2237 WWW.CT.GOV/CAES An Affirmative Action/Equal Opportunity Employer